Biostatistics/Bioinformatics Core

Project Summary/Abstract
The overall goal of the Biostatistics/Bioinformatics Core (Core B) is to provide state-of-the-art biostatistics
and bioinformatics support to ensure the rigor of the science and operations within the Cervical Cancer SPORE
by participating fully in the design of preclinical studies and clinical trials, validation of assays, database systems,
quality control of data and specimen management, and the statistical analysis, interpretation, presentation and
sharing of data by consultation and collaboration throughout our infrastructure at the Johns Hopkins University
(JHU), University of Alabama at Birmingham (UAB), the University of Colorado at Boulder (UCAB), and Medical
University of Vienna (MUV). Core B will provide centralized biostatistical and bioinformatics services and
molecular assay validation support as well as collaborative research and data management support for the
research projects of the SPORE. Core B will serve as the focal point from which the SPORE investigators,
including developmental research program (DRP) and career enhancement program (CEP) awardees, draw
upon statistical expertise for their research projects. The Specific Aims of Core B are to: 1) Provide biostatistical
and bioinformatical consultation and support by assisting in experimental design and data collection,
visualization, analysis, quantitative modeling, interpretation, publication and sharing for all SPORE projects. 2)
Provide biostatistical and bioinformatical support for the Tissue/Pathology/Immunology Core C, the
Developmental Research Program (DRP) awardees, and the Career Enhancement Program (CEP) awardees.
3) Advice and support the development of centralized facilities and protocols for data storage, management, and
dissemination. And 4) Support HPV and other molecular testing development and validation that complies with
CLIA regulations for the clinical testing proposed in the SPORE projects and provide biomarker assay research
methodology and experiment design support for the Tissue/Pathology/Immunology Core C, the DRP awardees,
and the CEP awardees. Each project has a primary biostatistician/bioinformatician thoroughly versed in the
subject matter associated with the project. Core members also interact on a regular basis and work closely with
the Administrative (Core A) and Tissue/Pathology/Immunology Core (Core C), which contributes to interactions
and synergy among the projects. Core investigators have extensive experience in a wide range of biostatistical,
bioinformatics, and translational research methodologies and applications, and molecular testing expertise, and
have also developed novel methods, some of which will be applied in this SPORE.